Mount Sinai HHEAR Network Targeted Lab Hub

Overall PROJECT SUMMARY/ABSTRACT
The Icahn School of Medicine at Mount Sinai will leverage our research expertise in environmental
epidemiology, analytical chemistry and clinical practice to renew our Human Health Exposure Analysis
Resource (HHEAR) Laboratory Network Hub (formerly known as “CHEAR” in grant cycle 1). We will measure
targeted chemical exposures across all life stages to help NIH funded researchers determine how the
environment affects human health, development and risk of disease across the life span. In the last 3 years we
have expanded our laboratory resources to include liquid handlers to automate sample prep/aliquoting and
worked with data scientist to automate data processing to speed the pace of our jobs. In addition we doubled
the number of mass spectrometers from 7 to 14 and hired additional faculty all in preparation for this renewal
application. We will leverage our substantial institutional investments, including our new 30 million dollar
Institute for Exposomics, to serve the HHEAR Lab network and its NIH researcher clients. Our targeted
resource will analyze common exposure biomarkers (metals, pesticides, flame retardants, endocrine disrupting
chemicals, tobacco metabolites, vitamins, nutritional status, minerals, and other organic compounds) using
state-of-the-art analytical methodologies, while developing new biomarkers of chemical exposure based on the
needs of our NIH clients. We will further build upon our work in CHEAR in which we created a suite of
customizable panels that facilitate research in complex chemical mixtures. Our Developmental core will build
upon its highly successful work in creating novel methods to measure current and past chemical exposures in
novel biological matrices (e.g. teeth, hair, dried blood spots, placenta) and develop new assays that arise from
hits from HHEAR's untargeted and environmental resources. This team already developed methods to
objectively reconstruct past chemical exposures and identify susceptibility windows as they relate to human
health in CHEAR. Our Administrative Core will coordinate planning and communication internally among all
Hub components and externally with the HHEAR Coordinating Center, Data Center and the other HHEAR
Network Hubs. Internally, the Administrative Core will streamline and prioritize HHEAR jobs, assess assay
needs, promote and disseminate new assays as they are developed, harmonize protocols and QA/QC
procedures and coordinate day to day operations. Our Hub will advise applicants on sample requirements,
sample quality, results interpretation, sample collection, storage protocols and sample shipping specifications
guiding them to exposures that fit the most up to date and innovative environmental health science. If
necessary we will outreach to outside laboratories with analytic capabilities/expertise that do not reside in our
Lab Hub. In conclusion, this proposal links highly experienced environmental health scientists with physicians,
toxicologists, stress researchers, chemists, exposure scientists, epidemiologists, and computer scientists to
build the infrastructure and capacity to objectively measure human environments.

Public health relevance
PROJECT NARRATIVE The Mount Sinai Human Health Exposure Analysis Resource (HHEAR) Laboratory Network Hub will advance public health in the United States by supporting state-of-the-art exposure science and biological response methods designed to discover the environmental causes of disease and disability in people of all ages.